Leveraging behavioral economics to equitably implement cascade screening in individuals with familial hypercholesterolemia in partnership with the FH Foundation

Project Summary
Familial hypercholesterolemia (FH) is a heritable disorder affecting 1.3 million individuals in the United States.
Eighty percent of people with FH have not yet been diagnosed, and this gap is even more robust for people from
minoritized populations, including Black or African American people. Family cascade screening is an evidence-
based practice that includes contacting and screening family members of people diagnosed with FH, but it is
rarely implemented representing a care gap in all populations, and particularly in Black or African American
people. The proposed work aims to use multi-methods to elucidate factors related to implementation of cascade
screening in Black or African American people in pursuit of identifying targets for future strategies to mitigate this
inequity. The parent grant supporting this Diversity Supplement is a hybrid effectiveness-implementation type III
randomized controlled trial testing the comparative effectiveness of two strategies to implement family cascade
screening with individuals with FH. Closing inequities in minoritized groups including African American or Black
people, Asian or Asian American people, and women across racial groups is a focus of the parent grant,
specifically by exploring equitable reach by sub-population, and in conducting interviews and centering diverse
voices. Under the primary mentorship of Dr. Rinad Beidas, the candidate, Ms. Chynna Mills, will extend the aims
of the parent grant using an established framework for health behavior to examine understudied multi-level
factors using multi-methods that may be related to reach of family cascade screening for Black or African
American people. In Aim 1, Ms. Mills will examine the relationship between a set of theoretically informed multi-
level candidate variables and the primary outcome (reach) in 100 Black or African American probands. In Aim 2,
Ms. Mills will explore mechanistic pathways of cascade screening reach via qualitative interviews. Ms. Mills has
prior experience examining multi-level factors impacting Black or African American people’s participation in
health interventions and is committed to a career as an independent investigator focused on improving
implementation of and engagement with evidence-based practices for Black or African American populations.
This Diversity Supplement will support the candidate’s development of an independent program of research
through mentored training. Results will offer insights on how to close inequitable gaps in implementation of
cascade screening with Black or African American populations and has the potential to lessen disparities in reach
of family cascade screening for Black or African American people with FH and other heritable genetic disorders.

Public health relevance
Project Narrative This Diversity Supplement application will extend the aims of the parent grant by examining multi-level individual, cultural and social context factors that may be related to reach of family cascade screening for Familial Hypercholesterolemia (FH). Findings will fill gaps in knowledge about understudied factors contributing to inequities in family cascade screening among Black or African American people with FH. The career development plan outlined in this proposal will support the candidate’s career goal of becoming an independent investigator focused on improving health outcomes among Black or African American people.